Skeletal Health in Youth with Type 1 Diabetes and Gender Diversity

Adolescence is a critical window for building bone and interrupting endocrine function during puberty jeopardizes
peak bone mass accrual. In our parent study, we are finding that children with type 1 diabetes (T1D) have altered
bone structure at the start of peak bone accrual as compared to matched controls. Our preliminary data show
that trabecular area by high resolution peripheral quantitative CT (HRpQCT) is decreased in T1D. This deficit is
associated with worse glycemia, including higher time in hyperglycemia by continuous glucose monitoring (CGM)
and increased advanced glycation endproduct (AGE) accumulation by skin autofluorescence (SAF). Yet a
community that is likely at even greater risk than T1D for disrupted endocrine function during peak bone mass
accrual is transgender and nonbinary youth (TNB). Pubertal blockade by a GnRH agonist (GnRHa) in TNB can
prevent testosterone from increasing trabecular bone density and size and estrogen from increasing cortical
bone density. It is known that bone mineral density (BMD) by dual energy X-ray absorptiometry (DXA) is
decreased in TNB, especially with GnRHa use. However, there are almost no data about how volumetric,
compartment-specific microarchitectural bone accrual, strength and turnover are affected in TNB not on GnRHa,
and in TNB with the additional insults of GnRHa or T1D. The objective of this supplement is to expand our
ongoing study of T1D and control children to include gender diverse youth both before and during pubertal
blockade, with and without T1D, using volumetric, microarchitectural and bone turnover analysis to explore the
impact on bone acquisition of the independent and combined endocrine disruptions of gender diversity, pubertal
blockade and T1D. Our hypothesis is that expanding our cohort to include TNB enables the study of TNB skeletal
health, with and without T1D. We further hypothesize that the preferential trabecular deficit that we observed in
T1D with hyperglycemia will be exacerbated in TNB, especially with GnRHa use. To attain the overall objective,
we will compare bone geometry, microarchitecture, trabecular morphology, microfinite element analysis (µFE)-
derived bone strength and turnover in TNB youth with and without T1D. In 30 TNB (10 T1D, 20 non-T1D) before
or during pubertal blockade, prior to cross-sex hormone treatment, we will perform once identical measurements
to the parent study: Tanner stage, bone age; bone size, areal BMD and body composition by DXA; volumetric
BMD, trabecular and cortical microarchitecture and µFE-derived bone strength by HRpQCT; trabecular
morphology by individual trabecula segmentation (ITS); turnover by markers of formation and resorption and sex
steroids by biochemistries; glycemia by HbA1c and CGM, and AGE accumulation by skin autofluorescence. We
expect these exploratory data to inform the development and implementation of future prospective clinical trials
of bone health for T1D with the unique health concern of TNB, as well as for TNB without T1D, from initiation of
GnRHa through cross-sex hormone treatment. This will set the stage for mitigating future fracture risk in T1D
with the disparity of TNB, as well as in TNB without T1D, and improving lifelong bone health outcomes.

Public health relevance
Our parent study is showing that children with type 1 diabetes (T1D) have altered bone structure by high resolution state-of-the-art imaging as they enter the window of peak bone accretion. This supplement will expand our study to include transgender and nonbinary youth (TNB) with and without T1D, a community that is likely at even higher risk for disrupted bone accrual, and in which there are almost no data using high resolution bone imaging. These data will inform the development of future prospective clinical trials of bone health for T1D with the unique health concern of TNB, as well as for TNB without T1D, setting the stage to improve lifelong bone health outcomes.